Care Assistant for Family Caregivers of Alzheimer Patients During Out of the Home Activities

Abstract Increases in life expectancy together with demographic trends have fueled a rapid increase in America's elderly population. As the number of older Americans has grown, so has the prevalence of aging-associated diseases, including Alzheimer's Disease (AD) and dementia. An estimated 5.4 Million Americans had AD in 2012, that number is expected to double by 2030. It is estimated that most these patients (70%) live at home where they receive 75% of their care from informal caregivers, unpaid individuals such as family members, friends, and neighbors. The natural progression of the disease and its burdensome behaviors cause significant stress for caregivers who frequently have close relationships to the patient. Among caregivers of dementia patients, wandering behavior is one of the most stress-provoking symptoms. Wandering is a common symptom that encompasses various walking behaviors that can result in the patient becoming lost or disoriented leading to the risk of serious injury or death for the patient and stress and reduced independence for the caregiver. Family caregivers often cannot leave patients home alone, and instead must bring them on errands to large complex indoor environments. Koronis Biomedical Technologies will develop a prototype patient tracking solution that will give peace of mind to caregivers in both stationary and mobile scenarios, alerting the caregiver to wandering behavior and allowing them to quickly locate their loved one. It will consist of a monitoring system that features geo-fencing and tether modes for both indoor and outdoor use. Feasibility and usability of the prototype system will be assessed by family caregivers through a series of focus groups, as well as engineering evaluations.

Public health relevance
Narrative Informal and family caregivers provide three quarters of the care for America's dementia population at a great economic and emotional cost to themselves. These caregivers experience significant stress due to the burdensome behaviors associated with dementia. A significant source of stress is associated with a common disease behavior known as wandering or elopement. The proposed research seeks to develop a comprehensive caregiver tracking assistant device to reduce these burdens, and to facilitate greater caregiver independence.